Multi-Disciplinary Training Grant in Cancer Research

Program Summary
The Multi-disciplinary Training grant in Cancer Research (MTCR) is a pre-doctoral training program at
the University of Chicago supported by NIH/NCI T32-009594 that trains our most talented pre-doctoral
students to understand and target cancers using multi-disciplinary approaches. Pre-doctoral trainees are
appointed to the MTCR T32 at the end of their first or second year in graduate school from feeder
graduate programs, and are appointed for a minimum of one year, and usually reappointed for a second
year, based on performance review of the past year in the program. Through stringent selection of faculty
trainers, evolving coursework and training elements in translational cancer research, chemical biology,
molecular engineering and computational approaches, the MTCR program provides opportunities that
are multi-disciplinary and emphasize problem-based learning and hands-on experience. The MTCR also
promotes effective career development through the MyCHOICE program and the Polsky Center for
Entrepreneurship & Innovation where our trainees are exposed through seminars, workshops and
internships to skills relevant to a career in biotechnology, science journalism and other research-
intensive/related careers. In the past cycle, we have developed more effective mechanisms for trainee
recruitment from diverse backgrounds, through deployment of current trainees and our alumni network,
in combination with more holistic rubrics for recruitment. As a result, our program is more diverse than
ever, has shown enhanced training outcomes in terms of publications, fellowship awards and percent
trainees going into research-intensive and research-related careers, as well increased engagement of
our trainees both in the community, where our trainees have led many COE and DEI initiatives and also
in biotechnology, where our trainees are now actively engaged in building collaborative research
networks across the United States. Over the next 5 years with renewed funding, we aim to build on our
successful approaches, while continuing to review and enhance existing training, for example through
increased translational interactions as our new UChicago Cancer Pavilion (the first ever freestanding
Cancer Center in Illinois) comes online in 2027, and with the new CZ Biohub Chicago. Our ultimate goal
is to ensure that our pre-doctoral trainees, who are the next generation of cancer researchers, have the
knowledge, skills and motivation to make a meaningful impact on the collective goal of minimizing cancer
deaths in our time.

Public health relevance
Program Narrative The Multi-disciplinary Training grant in Cancer Research (MTCR) at the University of Chicago provides cutting edge training opportunities in cancer research to our pre-doctoral students through increased synergistic research activities in basic biology, clinical research, computational biology, chemical biology and molecular engineering, that are most relevant to the translation of cancer research discovery into the clinic. Our training program aims to imbue MTCR trainees with the knowledge, skills and understanding to maximally leverage the ever-increasing amounts of information about cancer as a disease to make a meaningful impact on the collective goal of eliminating cancer deaths in our time.